HYPOTHALAMIC/PITUITARY/ADRENAL AXIS FUNCTION &BRAIN MORPHOLOGY IN DRUG ABUSE

ACTH/cortisol function will be investigated in three groups of children between 10 and 19 years of age through the use of cognitive challenge, salivary cortisol collection, and volumetric measurement of pituitary by MRI. The three groups will be healthy controls, subjects identified to have substance abuse and subjects at risk for substance abuse.